ESQM conformance with the Egg Regulatory Program Standards

Project Summary
RFA-FD-25-021
The California Department of Food and Agriculture (CDFA) supports the Egg Safety and Quality
Management (ESQM) program which is well positioned to participate in the Egg Regulatory
Program Standards (ERPS) implementation. The ESQM program was in the unique position of
being involved in the initial development of the ERPS, cooperatively, along with Iowa and the
U.S. Food and Drug Administration (FDA). This two-plus year continuation with ERPS allows
ESQM an excellent opportunity to continue conformance and expand the work, while
maintaining consistency and enhancing the food safety and quality consumer product goals and
missions of CDFA and ESQM.
In congruity with the FDA’s desired outcomes under this Cooperative Agreement, ESQM is
dedicated to achieving full conformance with the ERPS. ESQM’s goals are to build on the ESQM
regulatory foundation, contribute to the improvement of the ERPS, strengthen a foundation for
pursuing regulatory actions, improve the ESQM outreach and education for egg producers and
maintain a commitment to complete compliance and integration of the ERPS. Through this
funding opportunity, ESQM Senior Environmental Scientist Specialist and Environmental
Scientists will continue to work to achieve full conformance of all ERPS Standards. Additionally,
these goals also target further improvement and promotion of the ERPS as a national integrated
food safety system.

Public health relevance
Project Narrative RFA-FD-25-021 The mission of California Department of Food and Agriculture’s (CDFA) Egg Safety and Quality Management Program (ESQM) is to ensure that eggs sold in California are of known quality, origin, grade, and size and support the consumption of high quality, safe eggs. The implementation of the Egg Regulatory Program Standards (ERPS) will provide ESQM with a uniform plan to consistently evaluate and improve egg safety inspection programs to achieve the long-term goal of a sustainable standards program.